Integrated analyses of genetics, epigenetics, and gene expression

We conduct collaborative bioinformatics research and provide bioinformatics supports to the investigators of LCBG as well as other investigators within NIH and outside of NIH. We perform data analyses, develop analytic tools, help interpret results, and provide training and education. The data include whole genome sequencing, exome sequencing, bulk RNAseq, single cell RNAseq, ChIP-seq, ATAC-seq, Methyl-seq, proteomics (RPPA), metabolomics data, and microarray data. The analyses include differential gene expression, PCA/UMAP/Heatmap visualization, pathway/network analysis, survival analysis and clinical association, somatic and germline mutation analysis, DNA copy number analysis, Structural variations and RNA fusion transcripts, GWAS and epidemiology study, phylogenetics and population genetics analysis, constructing custom reference genomes, epigenomics and genetic regulatory network analysis, evolution dynamics, and mathematics and statistics modeling.